Project 4: Development and validation of Pencil Beam Scanning methodology for particle FLASH radiotherapy

Project Summary
This project will investigate spatio-temporal delivery of FLASH radiation using pencil beam scanning technology.
Modern Pencil Beam Scanning (PBS) technology can deliver spatially non-uniform (Gaussian-like) pencil beam
in very high instantaneous dose rate to both shallow and deep-seated tumors; however, the low dose tail of a
pencil beam and the relatively slow volume scanning speed for large targets generate a variable dose rate at
selected target or normal tissue locations. The impact of this spatial-temporal variation is still unknown for
FLASH. Even at the same (averaged) dose rate, degeneracy exists that the FLASH treatment can be delivered
by different time-dose sequences. There is a need to study the timing structure of dose delivery in the context of
FLASH treatment, as well as measuring and documenting each FLASH treatment so that the outcome can be
better understood. Our central hypothesis is that proton PBS can be optimized to deliver FLASH enhanced
radiotherapy with existing accelerator technology. The aims of the proposal are:
Aim 1 - Investigation of spatio-temporal variations and SOBP versus shoot through PBS beams.
Aim 2 - Development of a spatial-temporal biological effective dose model for PBS-based FLASH
proton therapy.
Aim 3 - Development of fast dose recording instrumentation, image guided positional systems, quality
assurance procedures, and end-to-end validation.
Success of this project will demonstrate the ability to deliver FLASH to large treatment volumes using proton
PBS for the first time. Combined with the ability of proton therapy to accurately deliver dose to deep targets,
this will allow translation of PBS FLASH proton therapy to early stage clinical trial studies.

Public health relevance
NARRATIVE This project will investigate the use of proton pencil beam scanning (PBS) to deliver FLASH enhanced radiotherapy. The approach will examine the complex interplay between spatio-temporal beam parameters and FLASH, optimization algorithms for modeling biological effects and treatment planning, and development of FLASH specific methods for ultra-fast dose monitoring, robotic positioning, image guidance, and quality assurance. The goal is to further optimize the FLASH effect by PBS machine tuning and FLASH delivery with existing clinical proton accelerator technology.